PROSTAGLANDINS IN CONTROL OF RENAL BLOOD FLOW AND RENIN IN HYPERTENSION

To determine if prostaglandins participate acutely and chronically in controlling renal blood flow and renin release in renovascular hypertension.